Neurodevelopmental, Health, and Economic Outcomes at Preschool Age in Former Very Preterm Infants Randomized to An Economic Intervention to Support Mother's Own Milk

Project Summary
Although most very preterm (born <32 weeks gestation) infants survive to discharge from the neonatal
intensive care unit (NICU), they remain at an increased risk for impaired cognition and other
neurodevelopmental impairments, obesity, chronic cardiometabolic conditions, and respiratory illnesses that
burden families and translate into high healthcare and education costs over the lifespan. Existing observational
studies in former very preterm children have suggested benefits associated with mother’s own milk (MOM)
feedings due to its numerous bioactive components, but these studies are limited by the inability to ethically
randomize very preterm infants to receive different doses of MOM. Our ongoing NIH-funded randomized
controlled trial, “Reducing Disparity in the Receipt of Mother’s Own Milk in Very Low Birthweight Infants: An
Economic Intervention” (ReDiMOM), tests the effectiveness of an economic intervention that mitigates the
maternal costs of providing MOM in the NICU. ReDiMOM provides an economic bundle to intervention group
mothers: free hospital grade electric breast pump rental, free pickup of pumped MOM from the home, and
payment for each day spent pumping to offset maternal opportunity costs. Both intervention and control group
mothers receive standard NICU-specific lactation care. This ethical randomization of an intervention to achieve
higher NICU MOM doses provides the first opportunity to obtain experimental evidence of MOM’s long-term
impact on health and economic outcomes into childhood. Through a second NIH-funded study examining
toddler-age outcomes in children previously enrolled in ReDiMOM, we are collecting comprehensive,
longitudinal data on MOM feedings, neurodevelopment, health, diet, adiposity, healthcare utilization, and
economic outcomes at 2 years of age. Although we have been very successful in enrolling and retaining
subjects in these studies, the far-reaching and costly complications of very preterm birth such as obesity,
hypertension, and asthma, are rarely diagnosed during toddler age. Leveraging the randomized design of the
ReDiMOM trial, the overall aim of this study is to continue the measurement of neurodevelopment, health, and
economic outcomes in former very preterm infants through preschool age (ages 3-6 years). Aim 1 is to
determine the effect of treatment group on outcomes at preschool age in former very preterm infants, including
primary outcomes of cognition and societal cost, and secondary outcomes of behavior, motor, and executive
function, health, and quality of life, and to evaluate the intervention’s cost-effectiveness. Aim 2 is to determine
the association between total MOM feeding duration through two years of age and preschool age outcomes.
This study will provide the highest quality of evidence for decision makers and essential economic data to
enable prioritizing investment in effective strategies that support MOM for very preterm infants and reduce
inequities in the receipt of MOM, ultimately leading to improved outcomes for all very preterm infants.

Public health relevance
Project Narrative This study will evaluate neurodevelopmental, health, and economic outcomes in preschool children born very preterm that participated in a randomized trial of an economic intervention designed to increase breastmilk feedings while they were in the neonatal intensive care unit.